Improving Lung Transplant Outcomes with Coping Skills and Physical Activity

ABSTRACT
For many patients with advanced lung disease, lung transplantation is the last viable treatment option to
improve their quality of life (QoL) and extend their survival. With the growing number of individuals suffering
from end-stage lung diseases, the frequency of lung transplantation has increased exponentially over the past
two decades; more than 2,500 patients have been transplanted in the United States in 2016, a number that is
expected to increase in the coming years. Despite advances in surgical techniques and medical management,
median long term survival has plateaued at about 6 years, and, surprisingly, mental health QoL may not
improve significantly after transplant. Developing treatments to extend life and improve QoL among individuals
with advanced lung disease is a public health priority. Low functional capacity, physical inactivity, and
heightened emotional distress are common following lung transplantation and are associated with increased
risk of mortality and re-hospitalizations. Therefore we hypothesize that improving psychological well-being and
functional capacity will further translate into improved QoL and better medical outcomes among lung transplant
recipients. Prior research has shown that coping skills training (CST), designed both to teach patients self-
management skills and to cope more effectively with psychological stress associated with chronic illness, is
effective for a number of chronic conditions including diabetes, ischemic heart disease, arthritis, and heart
failure. However, CST has not yet been evaluated as an intervention to facilitate self-management of lung
transplant recipients, an even more complex condition in which patient self-management, regular exercise, and
medication adherence are critical to successful outcomes. We propose a randomized clinical trial comparing a
12-week combined coping skills training and exercise (CSTEX) intervention with standard of care plus
transplant education (SOC-ED) in a study sample of 150 lung transplant outpatients recruited from Duke
University Medical Center and Washington University School of Medicine. The proposed CSTEX intervention,
delivered by respiratory therapists using mHealth technology, is designed to reduce distress and depression
and to improve key health behaviors, including physical activity, monitoring of pulmonary function, and
adherence to medication, which have been shown to be related to medical outcomes in transplant recipients.
Before and following treatment, overall distress and QoL indicated by both physical and mental health
functioning, will be assessed. Effects of CSTEX on clinical outcomes also will be evaluated over a median
follow-up period of 2.5 years. Findings from this trial could lead to the incorporation of coping skills training
and exercise promotion into routine self-management interventions as cost-effective approaches to enhance
disease management, QoL and medical outcomes in lung transplant patients and provide a basis for extending
studies to other populations of patients with advanced lung disease.

Public health relevance
Relevance Lung transplantation has become an increasingly common treatment option to improve quality of life (QoL) and extend survival in patients with advanced lung disease. More than 2500 patients were transplanted in the United States in 2016, a number that is expected to increase in the coming years. However, despite advances in surgical techniques and medical management, longer term survival has plateaued at about 6 years, and mental health QoL may not improve after transplant. Low functional capacity, physical inactivity, and heightened emotional distress are common following lung transplantation and are associated with increased risk of mortality and re-hospitalizations. The proposed study is a randomized trial designed to assess the benefits of coping skills training combined with exercise and promotion of physical activity in reducing symptoms of distress, increasing functional capacity, and improving clinical outcomes in lung transplant recipients.